Mitochondria-Nuclear Communication via Lactylation in Alzheimer’s Disease

PROJECT SUMMARY
In response to RFA-AG-25-026, “Investigating Mitochondrial-Nuclear Communication in AD/ADRD,” we propose
to investigate the overarching hypothesis that mitochondrial dysfunction in AD leads to increased glycolysis and
elevated lactate production, which induces lactylation of histones and non-histone proteins. This post-
translational modification (PTM), which conjugates lactyl groups to lysine residues on histones and proteins,
results in structural and functional nuclear damage, epigenetic alterations, and dysregulation of gene expression
in AD pathogenesis. We propose the following Specific Aims: 1) Investigate the effects of non-histone protein
lactylation on nuclear structure and functions through tau. 2) Investigate epigenetic changes through histone
lactylation in AD. 3) Characterize the effects of AD-patient-derived mitochondrial dysfunction in inducing both
histone and non-histone protein lactylation through increased glycolysis. Upon completion, this study is expected
to establish novel diagnostic and therapeutic targets against AD by focusing on lactylated histone and non-
histone protein proteins, an area that has yet to receive NIH support.

Public health relevance
PROJECT NARRATIVE This project investigates how mitochondrial dysfunction in Alzheimer's disease (AD) leads to increased lactate production, causing lactylation as a post-translational modification to proteins, including tau and histones. Aberrant Lactylation may damage the cell's nucleus, alter gene expression, and contribute to AD progression. By focusing on lactylation, this study could reveal new diagnostic and therapeutic targets for AD.